Immune Regulation of COVID-19 Infection in Cancer and Autoimmunity

Administrative Core
Abstract:
The administrative core for the Emory SeroNet U54 program will provide oversight and
management of the entire program. It is led by two investigators with considerable prior
experience in leading large multi-disciplinary teams. The leadership team will be
supported by dedicated staff for management support. An internal and external scientific
advisory board will provide oversight for this center. Core executive leadership group for
this center will consist of individual project and core leaders. The specific aims of the
administrative core are: Aim 1: To provide management and integration of center
activities and track progress of individual projects and core operations; Aim 2: To
provide oversight for trans-network projects and enhance participation in SeroNet
activities; Aim 3: To provide the infrastructure for center and program evaluation.

Public health relevance
Project Narrative: Not Applicable